Immunology Training Program-Predoctoral

Project Summary
The Case Western Reserve University (CWRU) School of Medicine (SOM) is a leader in immunology research
and education, with a rich history of seminal contributions to the field over many decades, including the discovery
of the alternative pathway of complement. The Immunology Training Program Leadership Track (ITP-LT) is a
training program within the broader Immunology PhD Program that is built to capitalize on the numerous
strengths of the institution and our affiliates, which includes multiple departments at CWRU SOM, University
Hospitals Cleveland Medical Center (UHCMC), the Cleveland Clinic Foundation (CCF; including the Lerner
Research Institute) and the Louis Stokes VA Medical Center (VAMC), to prepare PhD and MD/PhD scientists
for outstanding careers in immunology-related research. The Leadership Track places extra emphasis on
developing the next generation of investigative group leaders for academia and industry (pharmaceuticals and
biotechnology) as a central goal. Participating mentors provide a rich confluence of basic science, clinical
activities and resources, and career development workshops to enrich the training of PhD students as they
engage in basic and/or translational research ranging from innate immunity and signaling, T cell biology, antigen
processing and presentation, complement, antibody structure and function, and mucosal immunity to research
in clinically relevant models of infectious diseases (e.g. tuberculosis, HIV, malaria), immunopathology,
transplantation and autoimmunity. Moreover, CWRU SOM has a newly developed Center for Systems
Immunology (CSI) and has built a rare reputation for strength in glycoimmunology, or the role of glycans and
their binding partners in the immune response. The ITP-LT draws upon these strengths and enjoys the explicit
co-sponsorship by the CWRU Department of Pathology, CCF Department of Inflammation and Immunity,
CWRU/UHCMC Division of Infectious Diseases, and the CWRU Center for Global Health and Disease. These
unique research opportunities are central to the ongoing and future success of the ITP-LT. Training for the PhD
degree in the program includes course work, research rotations, formal and informal seminars, a Thesis Proposal
Defense/Qualifying Examination, research experience resulting in scholarly publications, career development
activities, a PhD dissertation, and a variety of opportunities to come together to share and celebrate the
accomplishments of the program's diverse population of trainees.

Public health relevance
Project Narrative The Immunology Training Program Leadership Track provides PhD training focused upon producing future group leaders in academic and industrial (pharmaceutical and biotechnology) settings who will drive important biomedical research efforts in immunology and immunology-related areas of clinical and basic science importance. This includes traditional topics such as infectious disease, vaccine development, organ transplantation, and autoimmunity, but extends to cutting-edge and rapidly developing subfields such as systems immunology and glycoimmunology.